Development of an ultrapotent anti-sperm antibody construct for non-hormonal contraception

Summary
Nearly half of all pregnancies in the U.S. are unintended, and most occur in women who are not using
contraceptives. There are diverse reasons for not using contraceptives; one common reason is that many
women have a strong aversion to using exogenous hormones due to real and perceived side effects. It is likely
that contraceptive use and satisfaction would substantially increase if there were a non-hormonal, user-
controlled contraceptive method that does not require coitally-timed actions nor daily dosing. Such product
does not currently exist. We believe we can create such a non-hormonal contraceptive based on an
intravaginal ring (IVR) releasing an anti-sperm antibody (ASA) that agglutinates and traps sperm in
mucus, thereby preventing sperm from reaching the egg. We were part of a consortium that advanced the
very first ASA into exploratory clinical studies, where we showed a high dose of ASA (HC4 IgG) given
immediately before intercourse was highly effective at eliminating progressively motile sperm in the cervix.
To further improve potency and create a product that offers sustained contraception, we previously
developed a multimeric contraceptive antibody, FFIFF, which targets the same well characterized and
validated sperm epitope as HC4 IgG, and could reduce progressively motile sperm by 99.9% in the sheep
vagina in 2 mins at a dose of just 33 ug per sheep. We have also developed a proprietary capsule-IVR
system that could stably release FFIFF and provide virtually complete sperm agglutination in sheep for over 20
days (more than adequate to cover the fertility window in most women). More recently, we have engineered a
next-generation ASA, LamH10, which possess even greater avidity and potency against sperm at
physiological temperature (37oC), exceeding the activity of the parent HC4 IgG by orders of magnitude. To
validate and advance LamH10 as the contraceptive antibody for our capsule-IVR platform, we will formulate
LamH10 into IVR and characterize both the release kinetics and activity/stability of released LamH10 in R61
Aim 1. We will then advance the LamH10-IVR into sheep study where we will assess the safety and sperm-
agglutinating potency across our targeted fertility window in R61 Aim 2. If we meet the R61 milestones by
validating the safety and effectiveness of LamH10-IVR as well as a cGMP cell line compatible with GMP
manufacturing of LamH10, we will focus the R33 phase on pre-IND filing (R33 Aim 1) and manufacturing of
GMP-grade materials (R33 Aim 2). Successful completion of these activities, combined with our other ongong
efforts, will put us in position to quickly advance LamH10-IVR into clinical study after the completion of this
project. This project represents a major milestone in our efforts to advance LamH10-IVR into the clinic to
address a significant unmet need in the contraceptive marketplace.

Public health relevance
Narrative Statement In the U.S., nearly half of all pregnancies are unintended, incurring a cost burden of over $20B to the federal and state governments each year. Here, we strive to advance our next-generation, ultrapotent anti-sperm antibody construct as an intravaginal ring (IVR) product, and, to complement our ongoing IND-enabling activities, produce clinical trial materials to support future clinical trials. Successful completion of this project will enable us to quickly advance our improved non-hormonal contraceptive IVR into clinical study.